BONE FABRIC MR MICROSCOPY OF TRABECULAR ARCHITECTURE

This project is complete and manuscripts presenting the results from these studies are being prepared for publication. (Training 1) REPORT PERIOD: (09/01/97-08/31/98)